Administrative Core

Abstract
Administrative Core
The Administrative Core will be responsible for the organizational needs for the entire P01 program,
ensuring an integrated and iterative collaborative process between all Projects and Cores to achieve outcomes
greater than any one group alone. Its roles and responsibilities include promoting team coordination and
synergistic interaction including regular sharing of ideas and findings, monitoring quality and progress in the
Projects, ensuring effective use of shared resources, administrative and fiscal management, completing ethical
approvals and renewals, tracking milestones, and resolving any conflicts. The Administrative Core will serve as
a hub for fostering inter-Project synergy and as a central coordinating center for scheduling Steering
Committee meetings and subgroup meetings, tracking milestones using shared project management software,
ensuring timely interactions between Project leads, and assuring regulatory oversight. The Administrative Core
will also serve as a liaison to public health and stakeholder groups that interface with the nursing homes
participating in prospective sampling efforts to ensure strong support. This includes assuring appropriate
awareness and support by each nursing home’s Quality Assurance committee and ombudsmen’s group. The
core will track budgetary spend down across all sites and serve as the point of contact for NIAID program
officials for communicating status and completing progress reports. In addition, a major effort for the
Administrative Core will be the request, tracking, inventory, and payment for thousands of nursing home charts
for review by Project 1 staff and investigators.